Characterization of Polysubstance Use: Combined Fentanyl and Methamphetamine

Project Summary
The opioid epidemic currently affecting the United States has entered a new wave of mortality, with combined
use of opioid and psychomotor simulants as a major contributing factor to the number of overdose deaths.
Combined use of fentanyl and methamphetamine may be due to a number of factors, including greater
rewarding effects, decreased negative side effects, and/or feelings that combined use is somehow ‘safer’ than
use of fentanyl alone. For those reasons, there is a clear need to examine the differences in the behavioral and
neurobiological alterations that occur following chronic use of fentanyl, methamphetamine, and these two
substances in combination. My preliminary findings suggest that there is enhanced hypodopaminergia
following combined use of fentanyl and methamphetamine (COMBO) when compared to fentanyl use alone. I
have determined that 1) in both male and female rats, elicited DA release was decreased in COMBO animals
compared to fentanyl alone animals and; (2) male COMBO animals had greater response rates and responded
more on a progressive ratio schedule of reinforcement. Therefore, this study aims to investigate the scarcely
studied combination of fentanyl and methamphetamine via a three-pronged approach examining behavioral
and neurobiological alterations to the DA system through self-administration, microdialysis and fast scan cyclic
voltammetry, and the use of the novel photosensor dLight during behavioral responding. Collectively, the
proposed aims will provide insight into the neurobiological and behavioral differences elicited by combined use
of fentanyl and methamphetamine, an under-studied topic that is highly relevant for the current state of the
opioid epidemic in the United States.

Public health relevance
PROJECT NARRITIVE Evidence suggests that the United States has entered a ‘fourth wave’ of mortality in the current opioid epidemic, largely due to increased overdose deaths associated with use of fentanyl (and other synthetic opioids) and co-use of methamphetamine and other psychomotor stimulants. Polysubstance use, which is very common in clinical populations, is understudied in preclinical research, which may contribute to the minimal number of effective treatments for opioid use disorder. Therefore, the proposed studies evaluate the behavioral and neurobiological effects and interactions of co-use of fentanyl and methamphetamine to identify adaptations to the mesolimbic dopamine system that are unique to polysubstance uses.